Clinical Implementation of Molecular Phenotypes of Critical Illness

ABSTRACT
Acute respiratory distress syndrome (ARDS) and Sepsis are frequently encountered in critical care and
lead to high morbidity and mortality. Despite decades of large clinical trials, other than antibiotics, no effective
pharmacotherapies have been identified. Heterogeneity in both syndromes is increasingly recognized as a
principal cause for these negative trials. To address this heterogeneity, we used latent class analysis (LCA) with
clinical data and protein biomarkers to identify two distinct molecular phenotypes, called the Hyperinflammatory
and Hypoinflammatory phenotypes. Independently, in multiple cohorts of ARDS and sepsis, the phenotypes
have different outcomes and responses to therapies, offering a potential route to precision-based trials.
Translating the phenotypes into the acute clinical setting has been challenging, as LCA models are incompatible
for bedside use due to their complexity and protein biomarkers that discriminate the phenotypes don’t have rapid
point-of-care (POC) assays. To address this, we have developed and validated a machine learning model, called
the clinical classifier model (CCM), which can assign phenotypes using vital signs and laboratory values only.
The primary objective of our proposal is to develop and validate an automated electronic health record (EHR)-
embedded CCM system that classifies molecular phenotypes at the bedside, enabling future phenotype-enriched
trials. Before such trials can be conducted, we need to broaden our understanding of the phenotypes and validate
the CCM comprehensively. First, we will evaluate phenotype transition and the CCM’s performance longitudinally
over time by using well validated biomarker-informed models to identify the molecular phenotypes in two previous
ARDS trials (ROSE and FACTT) and one observational cohort of sepsis (MARS) at multiple timepoints (Aim
1A). We will then evaluate the performance of the CCM to identify these phenotypes at each timepoint (Aim 1B).
Second, to enable bedside phenotype classification, we will develop an EHR-embedded CCM system that will
automatically extract its component variables and feed it to the CCM to enable rapid classification of the
molecular phenotypes (Aim 2A). We will silently run the EHR-embedded system in patients enrolled in the
PRECCISE cohort and validate it prospectively against biologically derived phenotypes at multiple timepoints
(Aim 2B). Third, comprehensive knowledge of the distinct epidemiology of phenotypes will enable more efficient
future trial design. To do this, after using the CCM to classify molecular phenotypes in 78,000 critically ill patients
with ARDS and Sepsis, we will use multistate modelling to map phenotype-specific hospital trajectories and
outcomes (Aim 3A). We will also use this cohort to determine optimal trial design factors by conducting
phenotype-specific target trials emulation of interventions previously associated with differential responses in the
phenotypes (corticosteroids, fluids strategy, and PEEP strategy) (Aim 3B). Completion of our specific aims would
be a game changer for precision medicine in critical care, as the EHR-embedded CCM system would harness
the clinical potential of the molecular phenotypes, paving the way for phenotype-enriched trials.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome and sepsis are common and deadly conditions that lack specific therapies due to their underlying heterogeneity. We have consistently described two molecular phenotypes in both syndromes that are biologically distinct and appear to respond differently to treatments; however, the clinical identification of the phenotypes is currently not possible because they rely on measuring biomarkers that lack a rapid point of care test. The goal of this project is to develop and validate an electronic health record embedded system that can use commonly collected vital sign and laboratory data to identify the molecular phenotypes at the bedside and enable future phenotype-enriched trials to test effective treatments.